Investigating Lipid-gene Molecular Profiles of Septic ARDS

Abstract
Sepsis is the most common cause (~75%) of acute respiratory distress syndrome (ARDS), a common condition
with over 40% mortality. There are no effective pharmacotherapies for ARDS, likely due to patient heterogeneity.
We have shown that HDL, which is usually anti-inflammatory/anti-oxidant, becomes dysfunctional (DysHDL) in
sepsis, and becomes a negative regulator of inflammation, lipid oxidation, and chemotaxis. DysHDL harbors an
altered proteome and lipidome when compared to normal HDL and has not been studied in septic ARDS. We
recently developed a panel of fifteen measurements including lipoproteins, inflammatory molecules, and clinical
features and established two new sepsis phenotypes, HYPO and NORMO. We applied our sepsis phenotyping
pipeline (preliminary data) to septic ARDS patients and found that HYPO septic ARDS patients had ~70%
mortality, lower apoA-I, HDL-C, low density lipoprotein (LDL-C), worse endothelial dysfunction (ICAM-1), and
higher organ failure severity when compared to NORMO septic ARDS patients (0% mortality). Moreover, HYPO
septic ARDS patient plasma contained significantly elevated lipoxygenase (LOX) pathway oxidized lipids (12-
HETE/15-HETE) compared to NORMO septic ARDS. We also identified six upregulated lipid metabolism genes
in peripheral blood leukocytes of HYPO vs. NORMO septic ARDS patients, critical for HDL/cholesterol
biosynthesis, lipid/drug metabolism, and bacterial toxin clearance. Our central hypothesis is that unique
phenotypes based on lipid-gene molecular patterns exist in septic ARDS that can be harnessed to reveal patient
molecular heterogeneity. We further hypothesize that HDL metabolism and the LOX pathway play critical roles
in septic ARDS, specifically in the HYPO phenotype subset. Our MPI team with unique expertise will address
major gaps in ARDS research by i) identifying novel septic ARDS phenotypes, ii) systematically discovering
repurposed drugs for septic ARDS treatment. Aim 1 will investigate HYPO/NORMO phenotypes in septic ARDS
patients, by measuring fifteen markers and DysHDL in 150 ROSE trial participant samples. We will perform
targeted lipidomics to quantify the oxidized lipidome of LOX, COX, and P450 pathways and obtain untargeted
transcriptomic signatures via whole blood RNAseq. We will localize expression patterns by cell type using single
cell RNAseq in a small subset. Aim 2 will determine novel septic ARDS phenotypes utilizing lipidomic and
transcriptomic profiles of septic ARDS patients. We will perform multi-omic, molecular phenotyping using an
unsupervised machine learning approach to uncover novel lipidomic/transcriptomic phenotypes and link
molecular phenotypes to potential drugs via drug-gene interactions.

Public health relevance
Project Narrative Sepsis is the most common cause of acute respiratory distress syndrome (ARDS), a common condition with over 40% mortality. No effective pharmacotherapies exist, likely due to patient heterogeneity. This translational research study will apply our novel sepsis phenotypes to samples from a large human ARDS study and perform multi-omic molecular phenotyping of septic ARDS to i) gain a better understanding of lipid-gene interactions in septic ARDS, ii) establish our novel lipoprotein-based phenotypes among septic ARDS patients, and iii) potentially discover repurposable drugs for septic ARDS treatment via drug-gene links.